Unique Antimicrobial Vascular Catheter to Prevent Catheter-Related Blood Stream Infections (CRBSI)

Abstract
The goal of this Phase I effort is determine the feasibility of developing a unique
antimicrobial catheter to reduce the instances of one of the most prevalent healthcare
associated infection, Catheter-Related Blood Stream Infection (CRBSI). This research
and development effort will be to develop an intravascular catheter with inherent long
lasting antiseptic properties to protect the patient and prevent infection. The proposed
device is a new approach to antimicrobial catheters. It will use common vascular
catheter designs and materials, with the addition of an antimicrobial polymer additive to
the elastomer to render the catheter antimicrobial. The unique additive replaces a
portion of the silica reinforcing filler in the elastomer and is designed to provide the
antibacterial agent to produce a permanent antimicrobial catheter surface. This
innovation is based on the development of an antimicrobial polymer that has self-
sterilizing properties that results in greater than six log kill of microorganisms inoculated
onto the surface. The additive filled elastomer used for the catheter shaft has been
tested against 10 common heath-care associated pathogens and has demonstrated a
greater than six log kill (99.9999%) in 2 hrs at body temperature. The antimicrobial
elastomer has also been demonstrated to be biocompatible passing a battery of tests.
In this Phase I research we will expand the biocompatibility testing to evaluate the
antimicrobial elastomer for suitability as an intravascular catheter.
Both the connecting hub and the catheter tubing will have antimicrobial properties that
will stop the primary access points for pathogens to the bloodstream. The catheter can
be manufactured inexpensively with standard medical tubing manufacturing processes
and materials, but will have the value-added property of antimicrobial activity. A durable
and effective antimicrobial vascular catheter that can prevent or reduce CRBSI will save
millions of dollars in healthcare cost and thousands of lives annually.

Public health relevance
Project Narrative Catheter-related bloodstream infections (CRBSI), is the most costly health-care associated infection (HAI) in terms of lives lost and financial cost. There are approximately 250,000 cases of CRBSI resulting an estimated 31,000 deaths annually in the US. The resulting increased hospital stays and increased antibiotic use results in an annual cost of an estimated 2 to 8 billion dollars to US healthcare. The proposed antimicrobial catheter has the potential for to greatly reducing the instances of bloodstream Infections and sepsis, saving millions of dollars and thousands of lives annually.